Improving awareness of women with hypertension: ROAR (Rural, Obese, At Risk) Career Enhancement Core

More than 1 in 3 women are living with heart disease and many are unaware of the risks. Hypertension
is a major modifiable risk factor for cardiovascular disease (CVD), and ~47% of adults in the US have
hypertension. In ~85% of cases, the cause of hypertension is unknown and only ~50% of patients
taking medication achieve blood pressure (BP) control to recommended levels. A critical barrier to
limiting premature death from CVD is lack of awareness surrounding the risks of CVD. The Career
Enhancement Core (CEC) is designed to develop a comprehensive educational platform on SABV in
CVD to increase awareness and education of CVD and the risks of uncontrolled hypertension in women
across the health span through community outreach. The CEC is critical to the success of ROAR. The
goals of the CEC are to develop a foundation for long-term relationships among the research, medical
and lay communities in GA, MS and SC, and bring greater awareness to the risk of CVD in women and
the consideration of SABV in the control of hypertension through education, mentorship, strategic
partnerships, and training of community-engaged researchers. The ROAR-CEC has 3 objectives.
Objective 1 is to develop a culturally diverse research pipeline of biomedical scientists trained in the
field of SABV in CVD. This Objective will provide research career enhancement opportunities in SABV
research, train a diverse scientific workforce, and promote mechanistic studies in SABV at different
career stages. Objective 2 is to establish a community outreach pipeline of scientists trained to
increase awareness of SABV and promote optimal cardiovascular healthcare for men and women.
ROAR-CEC will leverage and strengthen existing community partnerships to engage in outreach to
promote awareness about cardiovascular risk to men and women at local schools, colleges and
HBCUs. Objective 3 is to empower the community to self-monitor and identify barriers to improving
access to healthcare. This will be accomplished through innovative educational materials and
qualitative assessment of barriers. ROAR-CEC takes a comprehensive approach to training and
education in SABV in CVD and increasing community awareness of the risks of CVD. Our
interdisciplinary team is uniquely prepared to address these important issues in at-risk populations in
the Southern US. The impact of ROAR-CEC will be to train the next generation of scientists engaged
in research related to women’s health and SABV, to change common perceptions and biases regarding
women’s health and hypertension risk factors, and support the development of a new, self-aware,
sustainable, and motivated community of researchers, educators, physicians and community members.
ROAR will create synergy that will transform academic, clinical and community awareness of the
importance of cardiovascular health in women.

Public health relevance
Cardiovascular disease and hypertension remain leading causes of preventable illness and death, with women, particularly in underserved communities, facing heightened risk due to limited awareness and gaps in care. The ROAR Career Enhancement Core addresses these challenges by training scientists and community-engaged researchers to integrate sex as a biological variable into cardiovascular research while increasing public awareness, education, and self-monitoring of blood pressure. By building a rich, well-trained workforce and empowering communities across the Southeast, this Core aims to improve cardiovascular health and lower the long-term burden of cardiovascular disease.